Development of small molecule selective inhibitors of neuronal nitric oxide synthase (nNOS) for melanoma treatment

SUMMARY
Cutaneous melanoma is the most aggressive form of skin malignancy. Despite the revolutionary
developments of treatment using immunotherapy and targeted therapy, the 5-year survival rate of metastatic
disease remains low (~32%). A significant proportion of melanoma patients do not respond to the existing
therapies, and the treatment options become even more limited when patients develop resistance over time.
Our interdisciplinary team has demonstrated that neuronal nitric oxide synthase (nNOS)-mediated nitric oxide
(NO) signaling plays an essential role in melanoma progression and immune checkpoint PD-L1-mediated
immunosuppression. Inhibition of nNOS showed great promise in inhibiting melanoma progression and tumor
growth. Despite its clear potential as a therapeutic target, few successes have been achieved in developing
selective nNOS inhibitors, given the high structural similarity among the three isoforms of the nitric oxide
synthase enzymes.
With two decades of continuous effort, we successfully elucidated the structural basis for a group of highly
selective nNOS inhibitors; Using our approach, two compounds, HH044 and MAC-3-190, demonstrated potent
anti-melanoma activity in vivo, both when used alone and in combination with immune checkpoint inhibitors. Our
central hypothesis is that orally bioavailable small molecule inhibitors targeting nNOS represent a novel
strategy for melanoma treatment, particularly in combination with immune checkpoint blockade (ICB).
The proposed study aims to design and synthesize novel nNOS inhibitors with improved inhibition potency,
nNOS selectivity, and pharmacological properties, and evaluate their therapeutic potential and underlying anti-
melanoma mechanisms.
In Aim 1, we will use a structure-based approach to develop more potent and selective nNOS inhibitors with
improved oral bioavailability, followed by screening for anti-melanoma activities. In Aim 2, we will conduct
mechanistic studies to determine the on-target effects of nNOS inhibitors and to understand the molecular
mechanisms of nNOS inhibition in melanoma cells with distinct genomic mutation backgrounds. Aim 3 will
explore the mechanisms and therapeutic utility of nNOS inhibitors as a sensitizing therapy to improve checkpoint
blockade immunotherapy using a syngeneic, immunologically responsive mouse melanoma model and patient-
derived melanoma organoids. Successful completion of the proposed study will develop structure-based,
mechanism-driven, first-in-class orally bioavailable small molecules targeting nNOS for melanoma therapy alone
or in combination with ICB.

Public health relevance
NARRATIVE Human cutaneous melanoma is one of the few cancers in which the incidence rate continues to increase, and despite the recent advances in immune and targeted therapies, the 5-year survival rate of the metastatic disease remains low, at approximately 32%. An enzyme called neuronal nitric oxide synthase (nNOS) has been identified as contributing to melanoma development, stimulating disease progression, and facilitating the escape of melanoma cells from the immune response. This project aims to develop selective and potent nNOS inhibitors as a novel therapeutic strategy to improve the treatment of melanoma.